Leadership, Planning and Evaluation

LEADERSHIP, PLANNING AND EVALUATION (LPE)
PROJECT SUMMARY/ABSTRACT
Responsibility for planning and evaluation activities at Rutgers Cancer Institute of New Jersey (CINJ) rests with
Center Director, Steven K. Libutti, MD, FACS who sets the vision for and leads the Strategic Planning process,
participates in evaluation activities, and directs and supports Strategic Plan enhancements. The reporting period
for this application spans the last three years of our previous Strategic Plan and the first two of our current plan
(2021 – 2025). The Strategic Plans drove the evolution of the Center and accelerated progress toward
achievement of our research vision, stability through tremendous growth and change, increased research
collaborations, impact on catchment area, improvements in training and education, and plans to enhance
diversity. Our Senior Leaders (Center Director – Steven Libutti, Deputy Director – Eileen White, and Associate
Directors for Basic Research – Zhiyuan Shen; Clinical Research – Howard Hochster; Population Science and
Community Outreach – Anita Kinney; Translational Research – Shridar Ganesan; Consortium Research –
Yiban Kang; Education and Training – Edmund Lattime; Shared Resources – Adam Berger; Diversity, Equity
and Inclusion – Haejin In; and Administration and Planning – Linda Tanzer) each have well-defined roles and
work collaboratively to drive scientific progress that addresses the needs of our catchment area. Our primary
advisory bodies, which include our External and Internal Advisory Boards, Consortium Steering Committee, and
Community Cancer Action Board (CCAB) engaged key stakeholders and provide valuable insights in alignment
with the Strategic Plan. Selected planning and evaluation achievements of Leadership include: 1) launch of a
new five-year Strategic Plan with a vision and core values enhanced by communication with the new CCAB;
2) expansion of the role of our new Associate Director for Community Outreach to incorporate oversight of
Population Science; 3) recruitment of a new Associate Director and development of an Office of Diversity, Equity,
and Inclusion; 4) recruitment of a new Associate Director and Assistant Director for Shared Resources and
development of an Office of Shared Resource Management; 5) 93% increase in accruals to interventional
therapeutic studies with statewide impact; 6) growth in CINJ signature efforts in immunology and metabolism to
include a) establishment of a new Immunology and Metabolism center, b) a developing program in Cellular
Therapy, c) operationalization of a GMP facility, d) strengthening the Cancer Metabolism and Immunology
(formerly Cancer Metabolism and Growth) Research Program through better integration of the immunology aim,
and e) accelerating research in cancer metabolism through stronger relations with Princeton University including
a joint partnership in the new Ludwig-Princeton Branch; 7) establishment of the Immune Monitoring Core as a
new Shared Resource; and 8) dramatic expansion in our cancer screening initiative for underserved regions of
our catchment area (navigation to >52,000 cancer screenings). These achievements contributed to an increased
cancer focus, shown by the 22% growth in peer-reviewed cancer-focused funding (17% increase in NCI funding).

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)